Copper Sensing in Uropathogenic Escherichia coli

PROJECT SUMMARY
Significance: Urinary tract infections (UTIs) are the most common adult bacterial infection annually affecting
over 150 million individuals worldwide. As a common reason for antibiotic prescriptions, UTIs are considered a
substantial source of resistance to antimicrobial agents. Thus, improved understanding of the interactions
between host and bacterial pathogen during UTI is essential for facilitating the development of new therapeutic
agents. The concentration of copper increases 5-fold in the urine during acute infection as a protective strategy
against the pathogen. Most copper is excreted in the intestines where uropathogens colonize following UTI
forming the basis for recurrent infections. Uropathogenic Escherichia coli (UPEC), the most common cause of
UTIs, uses copper efflux and sequestration mechanisms to prevent copper toxicity. Additionally, UPEC inhabits
multiple niches (intestines, vagina, and bladder) throughout the host that vary in copper content and oxygen
concentration. While copper response mechanisms have been characterized in laboratory strains of E. coli, the
relative contribution of each copper response system to UPEC persistence in the host has not been elucidated.
This proposal will determine the spatio-temporal induction and regulation of the UPEC response to copper and
will define the role of each response system in mediating UPEC persistence in the host.
Rationale and Hypothesis: In order to successfully infect the urinary tract, UPEC must tolerate increased
copper levels. Similarly, UPEC must tolerate intestinal copper excretion to colonize the host gut and potentially
cause re-infections. Based on prior studies, the copper responsive UPEC locus cus is among the most
upregulated of all genes in samples from acute human UTIs. The cus locus encodes the two-component
signaling system CusSR, a copper sensing and response signaling system, and copper efflux apparatus
CusCFBA. Additionally, the copper response systems CueR/CopA facilitate copper export in aerobic conditions.
Oxygen availability is a key determinant of which copper response system is preferentially active in E. coli due
to the oxidation state of copper and energetic requirements for copper efflux. Oxygen levels vary widely within
UPEC’s niches. I hypothesize that oxygen availability and copper levels dictate the copper response
systems that are active in the anatomic niches that UPEC colonizes and infects. I propose two aims to test
this hypothesis:
Aims: Aim 1 will determine which UPEC copper response systems are active in the anatomic niches (vagina,
intestines, bladder) that UPEC encounters. Aim 2 will investigate the role of CusSR in mediating copper sensing
and tolerance in the anaerobic intestinal niche.
Impact: These studies will be the first to address the hierarchy and localization of copper response systems
uropathogenesis. Clarification of how UPEC senses and responds to copper will provide insight into whether
targeting copper detoxification methods of UPEC is a viable therapeutic option for UTI treatment and prevention.

Public health relevance
PROJECT NARRATIVE This proposal seeks to determine how bacteria sense and respond to changes in copper levels during urinary tract infection (UTI) and intestinal colonization. Copper levels increase in the urinary tract during infection as a protective mechanism against bacterial pathogens, yet the primary cause of UTIs, the bacteria called Escherichia coli have mechanisms to overcome copper stress and persist in the host. Our work will illuminate the pathways used by Escherichia coli to tolerate copper, opening new avenues for targeting bacterial copper detoxification mechanisms as a novel antimicrobial strategy.